A Comprehensive Psychoacoustic Approach to Voice Quality Perception

PROJECT SUMMARY/ABSTRACT
Voice disorders often lead to changes in voice quality noticed by patients, clinicians, and conversation
partners. Assessment of voice quality is essential for diagnosis, and improvement in voice quality is a critical
outcome of treatment. However, our knowledge of how voice quality is perceived is limited and the availability
of robust measures of clinical outcome is even more limited. This has restricted our ability to accurately
quantify or describe changes in quality, such as declines due to a disease or improvements resulting from
treatment. This continuation project combines concepts and techniques from voice science, speech science,
hearing science, and engineering to address these problems. The comprehensive approach to the proposed
research simultaneously envelops the three primary VQ dimensions, embraces their covariance, improves
measurement methods, and expands ecological validity through connected speech evaluation. The research
proceeds by first obtaining high-precision measures of voice quality perception in the laboratory. These data
are then used to develop mathematical models of voice quality perception that accurately reflect listeners’ data.
To obtain a close match between human judgments of voice quality and model output, models of auditory
processing are used to obtain an internal representation of the voice acoustic signal. Specific measures are
then captured from this internal auditory representation and used to model the perception of voice quality. In
the proposed work, these methods will be used to establish a comprehensive framework for understanding and
measuring voice quality perception and to enable translation to clinical practice. The specific goals of this
project are to: (1) develop a more complete understanding of the nature of VQ covariance (among breathy,
rough, and strain) using natural dysphonic voices; (2) assess VQ in connected speech at micro (segmental)
and macro (whole utterance) levels to better capture the impacts of rapid and complex transitions, co-
articulatory and prosodic variations, and unique VQ signatures related to specific pathologies; (3) incorporate
all of these components into a novel, three-dimensional VQ scaling procedure that is simple, intuitive, efficient
enough to be used clinically, and has ratio-level measurement properties; (4) use highly-predictive
computational models to overcome many of the limitations of acoustic analyses and perceptual evaluation; and
(5) evaluate full range of psychometric properties considered in test design and evaluation including reliability,
validity, sensitivity, and specificity. Perhaps most importantly, the goal is to develop an assessment that
accurately indicates responsiveness to change (i.e., disorder progression, treatment). These parameters are
considered essential for longitudinal assessment and outcome measurement. The feasibility of using these
models and metrics in regular clinical assessment will be evaluated in multiple voice pathologies through a
clinical field-trial and coordinated offline assessments by clinicians and laboratory subjects.

Public health relevance
PROJECT NARRATIVE The goal of this work is to transform dysphonic voice quality assessment in clinical practice and in research by establishing new psychometric scales that accommodate sustained phonation and connected speech. The multidimensional scales will be designed and evaluated with the goals of high validity, reliability, sensitivity, specificity, and most importantly, the responsiveness to change. These methods also will support development of precise, reliable and automated computational models of voice quality perception.